Cyclical deficits in emotion regulation as a risk factor for alcohol misuse in premenopausal females

PROJECT SUMMARY
Alcohol misuse is rising in females. As females may experience worse health consequences then males and
female-specific risks associated with alcohol misuse, elucidating female-specific factors is essential to build a
better understanding of alcohol misuse in females and the development of prevention strategies for alcohol
misuse in females. A small literature implicates dimensional premenstrual dysphoric disorder (dPMDD)—a
mood disorder characterized by clinically significant emotional, behavioral, and physical symptoms during the
late luteal that completely resolve by the mid follicular—as a critical female-specific risk factor for alcohol
misuse and luteal phase increases in alcohol use. However, no studies to date have evaluated the shared
physiological and emotional pathways of dPMDD and alcohol misuse. Emotion regulation encompasses the
awareness and identification of emotion, and strategies to modify the emotional response. Emotion regulation
may also be physiologically represented. Heart rate variability (HRV), an index of parasympathetic control over
heartrate, is considered a peripheral psychophysiological marker of emotion regulation. Reduced subjective
and objective (i.e., HRV) emotion regulation has been shown to associate with alcohol misuse. However,
studies have not investigated how cyclical changes in emotion regulation may act as a risk factor for alcohol
misuse and whether this differs between females with compared to without dPMDD. HRV shows the lowest
levels during the luteal phase and our pilot data shows greater luteal phase reductions in HRV map onto more
significant increases in luteal phase negative emotion. Our central hypothesis is that females with dPMDD
suffer from recurrent luteal phase increases in heavy drinking due to progesterone-related declines in HRV and
associated deficits in emotion regulation. The proposed study will recruit premenopausal females with heavy
alcohol use (50% dPMDD) who will complete 4 weeks of prospective screening; and 5 weeks of Ecological
Momentary Assessment (EMA) and HRV assessment. Aim 1 tests the hypothesis that dPMDD will show larger
luteal phase increases in alcohol misuse relative to no dPMDD. Aim 2 tests the hypothesis that cyclical deficits
in emotion regulation will predict cyclical increases in alcohol misuse. Aim 3 tests the hypothesis that individual
differences in the degree of HRV reduction from the follicular to the luteal phase will predict greater luteal
phase increases in alcohol variables. The results of this study will importantly contribute to the NIH strategic
plan for research addressing sex/gender differences and female health. Specifically, this study will provide
information on cyclical emotion regulation associations with alcohol misuse, which will provide foundational
information regarding the influence of emotion regulation in the context of heavy drinking and the etiologic
overlap between female alcohol misuse and emotion regulation in dPMDD.

Public health relevance
PROJECT NARRATIVE Alcohol use and misuse is rising in females, which makes it essential to identify female-specific risk factors for alcohol misuse. The proposed project will build a better understanding of cyclical changes in objective (heart rate variability) and subjective (self-reported) emotion regulation as a risk factor for cyclical alcohol misuse in females. By studying alcohol misuse changes across the most frequently-experienced reproductive sex steroid transition (i.e., the menstrual cycle), the results of this study will contribute critical information to NIAAA’s priorities for building a better understanding of alcohol misuse in females across the lifespan.